Dissecting the contributions of phase separation to yeast transcription .

Summary
Transcription requires the coordinated recruitment of transcription factors, coactivators, and regulators to speciﬁc
DNA elements with high spatial and temporal regulation. Phase separation has recently been implicated in the
regulated assembly of the transcriptional machinery, but it remains unclear to which extent and how phase
separation contributes to transcriptional activity. This is a bottleneck in our current understanding given the
importance of this fundamental biological process in development and its dysregulation in disease processes.
The small size of transcriptional assemblies is a technical challenge that we will circumvent here by employing
mutagenesis. Another challenge is the limited quantitative comparison of alternative models in the current
literature. Importantly, the existence of multivalent interactions does not necessitate that they give rise to function
via phase separation. E.g., multiple motifs in the yeast transcription factor Gcn4 bind to multiple binding sites in
its cognate mediator subunit Med15, generating multivalent, dynamic interactions that give rise to non-
stoichiometric, soluble complexes below the threshold concentration for phase separation. Thus, we hypothesize
that soluble complexes and condensates are mediated by the same multivalent interactions and serve similar
functions. We further hypothesize that transcriptional condensates have additional emerging properties that can
enhance or suppress transcriptional functions. Here, we propose to leverage a conceptual phase separation
framework recently developed by PI Mittag to generate separation-of-function mutants. Her rigorous approaches
for quantifying driving force for phase separation will be combined with extensive expertise on transcription and
its regulation by PI Ansari. We will perform the proposed studies in yeast because function can be analyzed in
vivo, and activity compared with well-deﬁned in vitro readouts. We will ask three main questions: 1) How do
transcription factors, coactivators and DNA phase separate together, and how do multivalent interactions and
solubility contribute to their phase behavior? 2) Is transcriptional activity of the yeast transcription factor Gcn4
driven by small complexes or by phase-separated condensates? 3) Given that condensates have emergent
properties that small complexes lack, how does the ability to include or exclude regulatory factors from
condensates and the ability to percolate and alter chromatin structure inﬂuence transcriptional function? The
overall impact of this project will stem from the careful quantitative and conceptual characterization of the phase
behavior of transcription factors with downstream factors. The rigorous comparison of alternate models will
reveal the role of phase separation in transcription and which functions of transcriptional condensates go beyond
those of small complexes. The proposed work is of high relevance given the interest in targeting transcriptional
condensates therapeutically in diseases.

Public health relevance
Transcription requires the coordinated assembly of many components in space and time. Phase separation has recently been implicated in this process, but it remains unclear through which mechanisms it contributes to transcription. Here, we will characterize the contributions of phase separation to inclusion and exclusion of regulators, to changes in chromatin structure and to driving transcriptional activity, with implications for the development of therapeutics that target transcriptional processes in diseases.